The Role of Tunneling Nanotubes and Mitochondrial programming in HIV-Associated Placental Dysfunction

PROJECT SUMMARY / ABSTRACT
HIV is known to be transmissible from mother to the developing fetus during pregnancy, leading to adverse
health outcomes for both. Although HIV is linked to placental pathologies, there is still a large gap in knowledge
about the mechanisms underlying HIV-associated pregnancy complications, despite four decades of research
in general on HIV topics. The objective of this project is to investigate the role of intercellular conduits composed
of F-actin microtubules that connect plasma membranes of neighboring cells enabling cytoplasmic continuing
and intercellular transfer of cargo. These conduits are known as tunneling nanotubes (TNTs). Recent
investigations by the PI and others have demonstrated that other viruses such as Zika and SARS-CoV-2 induce
the formation of TNTs in placental trophoblast cells, and there is evidence they serve as a means of mitochondrial
transfer and possibly viral transfer that promotes infectious spread. There is evidence that HIV induces TNT
formation in neurons, but it is not known whether the virus has this effect on placental cells. Building on prior
studies and ongoing work by the PI, the central hypothesis of this project is that HIV uses TNTs to spread
infection in trophoblasts, and that TNTs mediate placental dysfunction by transferring damaged mitochondria
and adversely reprogramming trophoblast metabolism. This metabolic reprogramming may contribute to
placental dysfunction and adverse pregnancy outcomes. Aim 1 of this project will elucidate the molecular
mechanisms of TNT formation between HIV-infected immune cells and trophoblasts. Aim 2 will determine the
impact of HIV on mitochondrial dynamics and transfer and resulting trophoblast function. These two aims will be
pursued during the final postdoctoral training period of the K99 phase. Aim 3 seeks to identify how HIV-exposed
mitochondria reprogram trophoblast biology, impairing placental function and affecting fetal development in vivo.
This third aim will be pursued during the R00 phase of the project. Successful completion of these aims will
provide new insights into the mechanisms underlying HIV infection, identifying potential therapeutic targets to
mitigate vertical transmission and placental pathologies caused by HIV and other viruses. During the mentored
phase, the PI will gain expertise in primary cell culture, metabolomics, trophoblast organoids, and mitochondrial
epigenetics to examine how HIV infects the placenta and disrupts cellular metabolism—establishing a foundation
for the R00 phase. With guidance from the advisory team, this training and research will contribute to the
identification of therapeutic strategies to improve outcomes for infants and individuals with HIV, while positioning
the investigator to establish an independent, competitive R01-funded laboratory at the intersection of HIV, TNTs,
placental biology, and mitochondria.

Public health relevance
PROJECT NARRATIVE The precise mechanisms by which HIV is able to replicate and spread within the placenta and transmit from mother to fetus remain poorly understood despite more than 40 years of research on various aspects of HIV pathology. This project investigates evidence that HIV replication and spread within the placenta is mediated by intercellular microtubules known as tunneling nanotubes (TNTs), which have been recently identified as a means of cytoplasmic continuity between adjacent cells induced by viruses to enable an immune-evasive pathway of transmission. Successful completion of the proposed studies will establish the role of TNTs in HIV infection, and open new pathways for therapeutic approaches to reducing the health risks for the mother and developing fetus due to HIV infection during pregnancy.